Determinants of Repeat Colorectal Cancer Screening in a Safety-Net System

PROJECT SUMMARY AND ABSTRACT
Colorectal cancer (CRC) is the second leading cause of cancer death in the United States and has a
disproportionate impact on low-income and ethnic minority populations. Screening has been shown to reduce
CRC incidence and mortality, but realizing its full benefits depends on recurrent screening at recommended
intervals over time, or repeat testing. Annual fecal immunochemical testing (FIT) is the screening modality
commonly used in low-resource safety net settings, given significant barriers to accessing colonoscopies that
allow less frequent screening. Although suboptimal rates of up-to-date CRC screening have been well
documented, less is known about repeat FIT or multi-level factors motivating FIT completion over time,
particularly in safety-net settings. Therefore, the purpose of the proposed study is to assess patient, provider,
and system level determinants of repeat FIT at a large federally qualified health center (FQHC). This project
builds on an established partnership between the Center for Cancer Prevention and Control Research and
Kaiser Permanente Center for Health Equity at UCLA and Northeast Valley Health Corporation (NEVHC), a
large multi-site FQHC that provides care for predominantly low-income and Latino patients, populations at
greatest risk for CRC screening underutilization. Using a mixed-methods approach, our specific aims are to:
(1) assess rates and correlates of repeat FIT over a 5-year period among patients with at least one index FIT
at a multi-site FQHC, using electronic medical record and administrative data and a clinic-based scan and
(2) characterize perspectives on barriers and facilitators of repeat FIT and experiences with clinic procedures
for FIT screening, using semi-structured qualitative interviews with patients, providers, and staff at NEVHC.
This project makes positive contributions to our understanding about repeat FIT among low-income, ethnic
minority populations receiving care in safety-net settings, and modifiable provider practices and clinic
procedures as intervention targets. Findings will inform the development of interventions to improve recurrent,
guideline-concordant FIT screening in low-resource clinical settings.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Colorectal cancer is a deadly disease but can be prevented with regular, repeated screening over time. The proposed study will assess repeat stool-based screening and identify barriers and facilitators to repeat screening in a large federally qualified health center. Information gained can help to address the needs of populations that experience elevated risk of poor CRC screening and outcomes and can be used to inform interventions for low-income and ethnic minority populations.